DISSOCIATION OF MUSCLE SYMPATHETIC NERVE ACTIVITY &VASCULAR RESISTANCE

The purpose of this study is to investigate how blood flow in the leg is regulated in humans when the level of nerve activity to these blood vessels and/or the pressure within these vessels is increased/decreased.